Research Capacity Core

PROJECT SUMMARY
The mission of Tuskegee University (TU) RCMI Research Capacity Core (TU RCC), also referred to as the Research Infrastructure Core (TU RIC), is to establish and sustain a supportive environment for biomedical research at TU, including reliable and state-of-the-art physical resources. These services, shared facilities, and equipment managed by the TU RCC provide the opportunity for the TU faculty to utilize, efficiently and synergistically, available resources and to collaborate internally and externally. TU, an HBCU, is an RCMI institution that receives funding from the NIH to develop and support comprehensive research programs focused on minority health—promoting innovative studies that address health disparities.